Access to medical care and health care utilization among low-income immigrants

Project Summary
There is growing policy activity among states and counties to use non-federal funds to offer health care
coverage to low-income, uninsured undocumented immigrants. However, there is only limited evidence on
undocumented immigrants’ health care utilization in the context of expanded access to care to support these
policies and guide their implementation. This R21 project will investigate one long-standing local program to
build the evidence base on how expanded access to care affects undocumented immigrants’ patient outcomes
and health care utilization. We will focus on patients enrolled in MyHealth LA (MHLA), the oldest and largest
local health plan for undocumented immigrants, located in Los Angeles County. MHLA provides a primary care
home at Federally Qualified Health Centers (FQHCs) and specialty, inpatient, and ED care through the county
health system for ~130,000 patients annually. This project will determine the impact of programs that expand
health care access to uninsured, low-income undocumented immigrants and understand how these patients
utilize care over time. Aim 1 of our project will use a unique data source of merged patient records, Medi-Cal
claims, and enrollment records from hospital encounters to determine whether MHLA patients have better (1)
ED and (2) inpatient outcomes than a matched sample of undocumented patients who are not enrolled in
MHLA (ED encounters>140,000 , inpatient encounters>46,000) between 2016-2022. This aim will provide
evidence on the impact of expanded access to care on patient outcomes by comparing enrolled and non-
enrolled patients. Aim 2 will look within the entire enrolled MHLA population to understand utilization over time.
We will merge MHLA enrollment records with Medi-Cal claims data from 2015-2022 to construct individual-
level panel data (n>90,000) to examine (1) ED, (2) outpatient specialty, (3) primary care, (4) hospitalized
inpatient, (5) preventive care, and (6) prescription utilization patterns 24 months after enrollment. We will
identify differences in utilization by important demographic characteristics (e.g race/ethnicity, age, language,
chronic conditions). This information can be used to distinguish subgroups with high utilization, set program
standards, and anticipate utilization patterns over time. We will also examine whether clinic characteristics and
external events (ie, COVID-19 pandemic) correlate with utilization patterns. The result of this study can be
used to help support the development of local and state-level policies that expand access to care for
undocumented residents as well as help policy makers, clinicians, and researchers anticipate outcomes after
these policies are implemented. We will work with a Steering Committee of FQHC leadership, MHLA
leadership, and community advocates to interpret and disseminate our findings.

Public health relevance
Project Narrative Despite growing policy activity to offer health care coverage to low-income, uninsured undocumented immigrants, there is only limited evidence on this population’s health care utilization in the context of expanded access to care to support these policies and guide their implementation. This R21 project will examine a long- standing local program that provides health coverage for ~130,000 undocumented patients annually to investigate how expanded access to care affects undocumented patients’ outcomes and health care utilization. We will use patient medical records, enrollment records, and Medicaid claims to provide evidence on the impact of expanded access to care on patient outcomes and understand ED, outpatient, inpatient, and prescription utilization over time.